Tailoring a patient engagement framework for substance use disorder research

PROJECT SUMMARY
Patient engagement in research and clinical practice holds promise for closing gaps across the substance use
disorder (SUD) use and treatment cascade, yet we currently have limited understanding of best practices for
patient engagement in the SUD field. We propose to engage in bioethics research to generate evidence
regarding key elements of SUD patient engaged research and clinical practice, and then tailor a patient
engagement framework for the SUD field. The project will result in a SUD patient engagement framework that
can be disseminated, applied, and evaluated in future work.

Public health relevance
PROJECT NARRATIVE Patient engagement in research and clinical practice holds promise for closing gaps across the substance use disorder (SUD) use and treatment cascade. Despite increasing recognition of the importance of engaging patients in SUD research and clinical practice, as well as NIDA’s commitment to patient engagement, we have limited understanding of best practices for patient engagement in the SUD field. Patient engagement frameworks are tools that help stakeholders support, evaluate, improve, and report on patient involvement in research and clinical practice. Yet, patient engagement frameworks that are tailored to the unique needs of patients and communities impacted by SUD are nascent. Therefore, our short-term goal for this project is to tailor a patient engagement framework for SUD research and clinical practice in partnership with the Addiction Policy Forum (APF), a nationwide organization dedicated to eliminating addiction. In Aim 1, we will engage in bioethics research to identify key elements of SUD patient engaged research and clinical practice via concept mapping. Concept mapping is a community-based participatory, mixed-methods approach that has been used in past work both to develop community engagement frameworks and with populations affected by SUD. We will follow recommended steps for using concept mapping in community-based participatory research, including: patient preparation, patient brainstorming, patient sorting and rating, multivariate statistical analysis, and patient interpretation. Participants will include individuals recruited from APF’s patient panels focused on individuals with active use (n=25) and in treatment and recovery (n=25). In Aim 2, we will tailor a patient engagement framework for SUD research and clinical practice. We will choose a patient engagement framework for tailoring by comparing results from Aim 1 to existing, well-established patient engagement frameworks. We will then tailor the framework by integrating results from Aim 1, and iteratively revise it with patients and experts in SUD research and clinical practice. This project will be conducted alongside our ongoing randomized controlled trial of a disclosure intervention for people in recovery from opioid use disorder (R01DA059557). We will therefore immediately apply the framework to our ongoing trial. Additionally, our long-term goals are to disseminate and evaluate the resulting SUD patient engagement framework. We will disseminate the framework via peer- reviewed publications and tailored, translated products for patients and other key stakeholders so that it can be applied to SUD research and clinical practice. We also plan to evaluate and, if needed, refine the framework in the context of future studies (e.g., with R21 or R01 funding). Our ultimate goal is to produce a SUD patient engagement framework that is flexible (so that it can be used with patients impacted by a variety of SUDs, who are engaged in active use and in treatment/recovery, as well as in both research studies and clinical practice) and adaptable (because the SUD epidemic is dynamic and often rapidly evolving).